Genetic determinants of TF binding in pooled microglia

PROJECT SUMMARY
Alzheimer's disease (AD) is an age-related neurodegenerative disease characterized by progressive cognitive
decline and dementia. Genetic studies of AD have identified 75 loci associated with susceptibility. Accumulating
evidence indicates that AD risk loci (both common and rare variants) are enriched for myeloid cell (monocytes
and microglia) expressed genes. We have previously demonstrated that AD susceptibility alleles affect myeloid
function by altering gene expression, splicing or chromatin. These AD-associated noncoding variants are highly
enriched in myeloid cell enhancers, but whether they affect enhancer function and binding of myeloid transcription
factors—and if so, how—remains largely unknown. The overall objective of this study is therefore to identify the
AD-associated common genetic variants that alters the binding of AD-relevant TFs in myeloid cells. In Aim 1, we
will perform Chromatin immunoprecipitation followed by sequencing (ChIP-Seq) by pooling microglia samples to
generate genome-wide profiles of PU.1, CEBPβ, MEF2C, BCL11A, BHLHE41, and CTCF, and histone H3 lysine
27 acetylation (H3K27ac) (TFs prioritized by AD genetics and functional genomics studies). In aim 2, we will use
a pooling-based approach to map transcription factor binding quantitative trait loci (bQTL). TF binding profiles
combined with RNA-seq (eQTL) and ATAC-seq (caQTL) data being generated from the same samples will allow
us to identify genetic effects on chromatin that propagate to gene expression. We will perform colocalization
analysis to identify AD susceptibility alleles that affect binding of TFs. The combined analyses of data on multiple
types of regulatory mechanisms will allow us to understand the basis for concerted changes in regulatory outputs,
and prioritize functional variants among statistically equivalent genetic associations. Finally, in aim 3, we will
validate the regulatory effect of binding-disrupting functional variants using massively parallel reporter assays
(MPRA) in human induced pluripotent stem cells (iPSCs) into induced microglia-like cells (iMGL). Together these
studies will not only further our understanding how AD risk variants affect disease process but also provide key
information bridging AD genetics to molecular mechanisms in microglia, setting the stage for future mechanistic
studies.

Public health relevance
PROJECT NARRATIVE Microglia has been identified to play a critical role in the progression of Alzheimer’s disease. However, a clear scientific gap exists in our understanding how these cells contribute to the disease at the molecular level. In this project, we will generate genome-wide binding profiles of AD-relevant transcription factors, proteins that controls expression levels of many AD-associated genes. These binding sites might be altered by AD risk alleles to affect gene expression in myeloid cells, which in turn may modulate disease risk. Understanding the mechanisms whereby genetic factors influence AD will lay the groundwork for future mechanistic studies that will elucidate disease pathogenesis and progression.